Rare earth nanoprobes for optical imaging and disease tracking (C3i)

PROJECT SUMMARY / ABSTRACT
This project is a C3i Accell administrative supplement to our ongoing R01 project (EB018358 “Rare-earth nanoprobes for
optical imaging and disease tracking”). The parent R01 project is developing short-wave infrared (SWIR) light-emitting
nanoparticle contrast agents and imaging instrumentation for use in fluorescence-guided surgery. In the R01 project,
mouse models of cancer are employed to evaluate the performance of these contrast agents in vivo.
Through the core C3i program, we learned that successful commercialization of this technology will require us to
demonstrate that contrast agent synthesis can be scaled to much larger volumes than used in our R01 murine studies,
while maintaining quality and consistency. We currently synthesize nanoprobes in individual 15 ml batches which are
sufficient to complete a typical longitudinal murine experiment, but inadequate for moving the technology forward into
large animal models and in-human clinical trials. To enable these future studies, this C3i Accell project will develop and
validate methods to synthesize nanoprobes at the 1000 ml scale. Nanoprobes will contain an erbium-doped nanoparticle
core providing SWIR optical emissions, encapsulated in human serum albumin for biocompatibility, with the small
molecule AMD3100 conjugated to the outer surface for targeting the CXCR4 tumor biomarker. To maintain uniformity in
nanoprobe properties at this scale and to demonstrate a scalable approach for commercial production, we will develop
synthesis methods using a continuous flow microfluidic platform.

Public health relevance
PROJECT NARRATIVE An narrative is not required for this submission; please see the Research Strategy section, which includes details on the parent grant.